Image Guided Delivery of Bioresponsive Hydrogels

Summary Myocardial infarction (MI) causes regional dysfunction placing remote areas of the heart at a mechanical disadvantage resulting in long term adverse left ventricular (LV) remodeling and complicating congestive heart failure (CHF), which remains a leading cause of morbidity and death in the Western world. The current project will focus on evaluating and modulating the critical balance of matrix metalloproteinases (MMP) and tissue inhibitors of matrix metalloproteinases (TIMP) which is known to play an important role during remodeling post-MI. A number of pharmacological and surgical therapies have been proposed to limit post-MI remodeling, including; the intramyocardial administration of biomaterials. These polymeric therapies have demonstrated mixed success in reducing infarct size, increasing angiogenesis, improving regional function, and limiting post-MI remodeling in pre-clinical studies, and have been recently translated to patients. We have established novel noninvasive hybrid SPECT/CT approaches for evaluation of changes in regional myocardial perfusion, angiogenesis, MMP activation, along with echocardiographic imaging approaches for quantitative evaluation of regional myocardial strain and ventricular remodeling. The current multi-PI proposal will focus on; 1) development of a novel imageable MMP-responsive theranostic hydrogel for post-MI therapy and tracking delivery and serial evaluation of hydrogel retention, 2) application of multimodality non-invasive anatomical, physiological and molecular imaging approaches for directing and evaluating the percutaneous intramyocardial delivery of MMP-responsive hydrogels, and 3) the evaluation of the mechanisms by which these injectable MMP-responsive hydrogels that release local TIMP alter myocardial mechanics and limit post- MI remodeling. We hypothesize that the intramyocardial delivery of MMP-responsive hydrogels that locally release TIMP-3 early post-MI will result in; 1) modulation of the local MMP-TIMP balance and the inflammatory response within the MI, 2) alteration of regional and global myocardial mechanics, 3) improvement in angiogenesis and myocardial perfusion, and 4) a reduction of adverse global post-MI remodeling. We also hypothesize that our multimodality imaging approach will facilitate optimal delivery of a theranostic hydrogel, and allow tracking of critical anatomical, physiological and molecular events, along with therapeutic efficacy. Accordingly, we propose to specifically: 1) development an imageable MMP-responsive theranostic hydrogels for post-MI therapy, 2) apply multimodality imaging to direct and evaluate percutaneous image-guided intramyocardial delivery these hydrogels using clinically relevant porcine models of post-MI remodeling, and 3) evaluate the mechanisms of therapeutic efficacy. The diagnostic and therapeutic approaches developed in the proposed project will be directly translatable to the management of patients following MI.

Public health relevance
Project Narrative Heart failure often complicates a heart attack and remains a major healthcare issue in the United States, resulting in annual costs that exceeds $30.1 Billion. We propose the development of a novel imageable polymer that can be directly delivered to the heart via a catheter under image guidance for local release of therapy early after a heart attack improving function and limiting the abnormal dilation of the heart that often occurs after the acute injury. This local image-guided therapy will improve the healing of the heart after a heart attack.